Impact of climate change on cognitive and physical aging of older kidney transplant recipients

Kidney transplantation (KT) is increasingly a treatment option for older (≥65) patients end-stage kidney
disease and KT recipients experience accelerated physical and cognitive aging due to years of reliance on
dialysis, as well as chronic disease comorbidity and immunosuppression to prevent graft loss. This has led us
to explore novel risk factors like climate change that may cause accelerated physical/cognitive aging and post-
KT outcomes. We hypothesize that various dimensions of climate change may cause accelerated
physical/cognitive aging and post-KT clinical outcomes among KT recipients and specifically older recipients.
First, rising ambient temperatures and frequent heatwaves lead to increased dehydration, hyperosmolality, and
electrolyte imbalances, all of which are known risks of graft loss and mortality. Our preliminary study shows
that exposure to high PM2.5 level, a cause of systemic inflammation, increases post-KT mortality 15%. The
meteorological interactions between climate change and air pollution may exacerbate the adverse impacts.
Second, older KT recipients are most vulnerable to climate change due to a lower physiological reserve, slower
metabolism, and decreased immune system. Air pollution and heatwaves may increase the risk for delirium as
well as cognitive declines which are the prevalent post-KT complications. Lastly, extreme weather events, such
as hurricane and ice storm, can increase risks for injuries and falls, especially among older adults with limited
physical functioning. To study climate change and health (CCH) in KT, we will leverage our ongoing
prospective cohort study, Frailty Assessment in Renal Disease (FAIR), which captures pre- and post-KT
measures of physical/cognitive aging and post-KT clinical outcomes on 1,469 adult (age≥18) KT recipients
residing in 39 states. We will glean 4 markers of climate change (long-term temperature change, heatwaves,
extreme weather events, and ambient air pollution levels) from publicly available data from the US National
Oceanic and Atmospheric Administration, National Aeronautics, and Space Administration Socioeconomic
Data and Applications Center. We will conduct a health effects epidemiology, one of the Core Pillars of
CCH/Diverse Areas of Science identified by the NIH. This supplement is highly relevant to CCH because we
seek to: 1. Quantify the impact of climate change on physical aging among KT recipients; 2. Test whether
climate change is associated with cognitive aging among KT recipients. 3. Estimate the risk of post-KT clinical
outcomes among recipients who experience climate change. The parent K02 proposal incorporates training
goals to establish novel risk factors for cognitive and physical functioning among KT recipients, and our
findings will enhance the K02 goals by incorporating novel aging risk factors, namely climate changes. This
supplement addresses a topic of interest to the National Institute on Aging: short- and long-term health impacts
of extreme weather and climate change on the health and wellbeing of older adults in the US.

Public health relevance
PROJECT NARRATIVE The proposed health effects epidemiology (CCH Core Pillar and diverse area of science) research will elucidate the impact of a multidimensional measure of climate change on accelerated physical and cognitive aging among kidney transplant (KT) recipients and will quantify the differential impact of climate change on older patients. We will also test whether climate change impacts post-KT clinical outcomes among older and younger patients. This epidemiology research will address the following National Institutes on Aging (NIA) topic of interest: short- (accelerated physical and cognitive aging) and long-term (clinical post-KT outcomes) impacts of extreme weather and climate change for older adults in the US.